Mutant Laminin Chains and Nephrotic Syndrome

DESCRIPTION (provided by applicant): Laminin (2 (LAMB2) is a component of Laminin-521, the major laminin trimer of the kidney glomerular basement membrane (GBM). Null mutations in LAMB2 cause Pierson syndrome, characterized by congenital nephrotic syndrome with severe ocular and neurological defects. In contrast, most missense LAMB2 mutations, such as R246Q, cause isolated congenital nephrotic syndrome. To investigate the mechanisms whereby missense mutations cause proteinuria, we have generated transgenic mice in which R246Q mutant (2 is expressed in podocytes at different levels and replaces normal (2 in the GBM. Our preliminary data show that these mice exhibit proteinuria that can be attenuated by increased deposition of mutant R246Q-LAMB2 into the GBM. Moreover, in vitro, secretion of mutant LAMB2 proteins is severely inhibited compared to wild-type. Therefore, we hypothesize that pathogenic LAMB2 point mutations cause protein misfolding, ER stress, and secretion defects both in vitro and in vivo. Chemical chaperones, such as taurodeoxycholic acid (TUDCA), are low molecular weight compounds that can stabilize protein conformation and rescue trafficking-defective misfolded proteins. We have shown that TUDCA treatment of cells expressing the mutants significantly increases the secretion of mutant LAMB2 proteins into the medium. We propose, therefore, that chemical chaperones can improve the folding of mutant LAMB2 proteins, reduce ER stress, and improve the secretion of mutant laminin trimers into the GBM, thereby attenuating proteinuria in Lamb2-/-; mutLAMB2 transgenic mice. To test these hypotheses, we will: 1. Examine whether LAMB2 point mutations cause protein misfolding and ER stress both in vitro and in vivo. 2. Determine whether chemical chaperones can improve the secretion of LAMB2 point mutants and reduce ER stress in vitro. 3. Investigate whether chemical chaperones improve secretion of mutant laminin (2 and attenuate proteinuria in Lamb2-/-; mutLAMB2 mice. These studies will help us to understand the molecular mechanisms underlying the pathogenesis of congenital nephrotic syndrome and assay the feasibility for therapeutic use of chemical chaperones in a relevant animal model. Our results may have significant therapeutic implications for the treatment of congenital nephrotic syndrome in patients carrying missense LAMB2 mutations.

Public health relevance
PUBLIC HEALTH RELEVANCE: Congenital nephrotic syndrome is an important childhood kidney disease which causes proteinuria and progressive renal failure. We are studying whether the administration of pharmacologically active chaperones can ameliorate proteinuria in an animal model. The results may indicate a new treatment scheme for renal proteinuric diseases. Project Narrative: Congenital nephrotic syndrome is an important childhood kidney disease which causes proteinuria and progressive renal failure. We are studying whether the administration of pharmacologically active chaperones can ameliorate proteinuria in an animal model. The results may indicate a new treatment scheme for renal proteinuric diseases. __SpecificAimsTextDelimiter__ Specific Aims The goal of this research is to determine the mechanisms by which laminin β2 (LAMB2) missense mutations cause isolated nephrotic syndrome in humans and in our mouse model, and to investigate a potential therapy. Our preliminary studies suggest that some LAMB2 missense mutations severely impair laminin secretion in cultured cells and in podocytes in vivo, which could cause endoplasmic reticulum (ER) stress. Our overarching hypothesis is that chemical chaperones will attenuate proteinuria and ER stress through improved folding and secretion of the mutant laminin from podocytes. Congenital nephrotic syndrome is a genetically heterogeneous disorder. The majority of cases have been attributed to mutations in the NPHS1, NPHS2, and WT1 genes. A recently described human disease, Pierson syndrome, characterized by congenital nephrotic syndrome and microcoria, is caused by null mutations in human LAMB2. More recently it was reported that the LAMB2 mutations R246Q and C321R cause isolated nephrotic syndrome without the extrarenal features of Pierson syndrome, while the R246W mutation causes a more Pierson-like phenotype. Thus far, the mechanisms whereby these LAMB2 missense mutations cause proteinuria remain unknown. Our in vitro and in vivo preliminary data suggest that defective secretion is likely involved; however, high level expression of a mutant R246Q- LAMB2 transgene in podocytes can overcome the secretion defect and protect against proteinuria. It has been demonstrated that missense mutations resulting in protein sequence variation can lead to the production of misfolded proteins that are unable to reach their functional destinations. Misfolded proteins are retained in the endoplasmic reticulum (ER), and their accumulation may cause ER stress and activate the unfolded protein response (UPR). Because the LAMB2 missense mutants R246Q, R246W and C321R are retained in cells rather than being secreted into the medium, we hypothesize that LAMB2 point mutations cause protein misfolding and ER stress, thereby inhibiting the secretion of laminin from podocytes into the glomerular basement membrane (GBM). Chemical chaperones are low molecular weight compounds that stabilize protein conformation, improve ER folding capacity, and facilitate the trafficking of mutant proteins. Therefore, chemical chaperones may potentially arrest or reverse disease. Our preliminary data show that TUDCA, a chemical chaperone, promotes secretion of mutant LAMB2 proteins in vitro. Thus, we hypothesize that chemical chaperones will reduce ER stress and improve the secretion of the mutant laminin β2- containing trimers into the GBM, thereby attenuating proteinuria in our mutant mice that express them. We propose the following Aims to test these hypotheses: Specific Aim 1. Test the hypothesis that LAMB2 point mutations cause protein misfolding and ER stress both in vitro and in vivo. LAMB2 point mutants described in human nephrotic syndrome have been engineered and will be expressed both in vitro (in transfected cells) and in vivo (in mutant transgenic mice). We will examine the subcellular localization of LAMB2 missense mutants and search for ER stress markers to determine whether these LAMB2 mutants accumulate in the ER and induce ER stress both in vitro and in vivo. Specific Aim 2. Test the hypothesis that diverse chemical chaperones and/or protein folding "correctors" can improve the secretion of LAMB2 point mutants and reduce ER stress in vitro. We will study the effects of chemical chaperones on the secretion of mutant LAMB2 proteins to investigate whether they alleviate ER stress and rescue the trafficking-defective LAMB2 mutants. In addition, by performing polymerization inhibition assays, we will determine whether mutant LAMB2- containing trimers might have an impaired ability to polymerize in the extracellular matrix to form and maintain the scaffold of the GBM. Specific aim 3. Investigate whether chemical chaperones affect secretion of mutant laminin β2 and attenuate proteinuria in Lamb2-/-; NEPH-mutLAMB2 mice. We hypothesize that chemical chaperones will improve the folding and secretion of mutant LAMB2-containing trimers into the GBM, ameliorate ER stress in podocytes, and attenuate proteinuria in Lamb2-/-; NEPH-mutLAMB2 mice, which express mutant laminin β2 in podocytes under control of the nephrin promoter. The results will have significant implications for the potential treatment of congenital nephrotic syndrome in patients carrying missense LAMB2 mutations.